Role of Central Neural NFkB and ER Stress in Obesity-induced Hypertension

DESCRIPTION (provided by applicant): Obesity is a major global health concern and is directly linked to the development of hypertension. Although a number of factors may contribute, accumulating evidence from humans and animal models indicate that excessive central sympathetic nerve activity (SNA) plays a pathogenic role in obesity-associated hypertension. However, the mechanisms by which cellular stressors, such as nutritional excess, translate into sympathetic overactivity and sustained elevations in arterial blood pressure remain unclear. A potential means is by evoking long-term changes in gene expression in central nervous system (CNS) cardiovascular neurons through the activation of inducible transcription factors, including nuclear factor kappa-B (NFκB). In this regard, there is mounting evidence that angiotensinergic signaling and endoplasmic reticulum stress (ER stress) within the brain are key mechanisms in diet-induced obesity (DIO); however the downstream molecular effectors remain unclear. Our key preliminary findings show that DIO-hypertension is mediated by angiotensinergic and ER stress mediated CNS mechanisms. We also provide exciting preliminary evidence that high fat diet (HFD) feeding in mice induces ER stress and NFκB activation in critical CNS neuro- cardioregulatory areas, including the subfornical organ (SFO) and paraventricular nucleus of the hypothalamus (PVN). Using an approach that combines genomic interventions, innovative imaging techniques and integrative cardiovascular physiological analysis in mice, we will test the overall hypothesis that Ang-II- induced ER stress-mediated activation of NFκB in the SFO-PVN axis mediates neurogenic hypertension induced by DIO. In Specific Aim 1 we will comprehensively profile NFκB in the SFO-PVN axis during high fat diet (HFD) feeding in mice. We will additionally examine a role for Ang-II-mediated mechanisms in driving NFκB activation during the development of DIO-induced hypertension. Based on evidence that ER stress pathways intersect directly with NFκB activation, in Specific Aim 2, we will examine a role for ER stress in mediating NFκB activation in the SFO and PVN during HFD. Finally in Specific Aim 3, during the independent portion of this proposal, the PI, Dr. Colin Young, will examine a functional role for NFκB in the SFO-PVN axis in mediating DIO sympathetic overactivity and hypertension. These studies have direct translation relevance to the setting of obesity-induced hypertension and build logically upon the PI's background in cardiovascular physiology and sympathetic neural recordings in humans. Furthermore, the findings from these investigations have the potential to significantly advance our understanding of the underlying molecular mechanisms driving DIO neurogenic hypertension, and may provide novel therapeutic target(s) for the treatment of hypertensive disease states. In addition, these studies have the potential to establish and advance a novel area of research, while at the same time providing a strong training and future research framework for the PI. The PI has extensive training in human neuro-cardiovascular regulation and is currently acquiring the knowledge and skills for applying genomic tools to investigate molecular integrative cardiovascular/autonomic function in mouse models of hypertension. As such, the mentored portion of this proposal (Aims 1 and 2) will uniquely position the PI to pursue future independent investigations (Aim 3) at the crossroads of basic molecular and integrative human translational research. The laboratory of Dr. Robin Davisson is the premier venue for the PI to pursue additional mentored training and perform the proposed studies, having been at the forefront of neural regulation and hypertension research over the past decade. In addition to advanced training in genomics, molecular biology and whole animal cardiovascular and autonomic physiology, the mentored guidance of Dr. Davisson and Cornell University provide a superb opportunity for the progression of career development and training in the responsible conduct of research. In addition to maintaining a strong research focus, the PI will pursue a number of exciting opportunities at the laboratory and institutional level to enhance his maturation as an independent scientist; including further development of leadership qualities, advancement of teaching skills and mentoring of trainees. Overall, this novel and exciting proposal has the potential to lay a strong foundation for the next independent phase of the PI.

Public health relevance
PROJECT NARRATIVE Obesity-induced hypertension and sympathetic overactivity is a major global health challenge, although the underlying mechanism(s) remain undefined. The central nervous system is directly implicated and understanding the molecular mechanisms in the brain, including transcription factor activation, will greatly advance our understanding of neuro-cardiovascular dysregulation in obese hypertensive conditions. __SpecificAimsTextDelimiter__ SPECIFIC AIMS: Obesity is a major global health concern and is directly linked to the development of hypertension. Although a number of factors may contribute, accumulating evidence from humans and animal models indicate that excessive central sympathetic nerve activity (SNA) plays a pathogenic role in obesity- associated hypertension. In this regard, activation of angiotensinergic signaling within the brain is emerging as a key mechanism in diet-induced obesity (DIO) hypertension; however, the downstream molecular effectors remain unclear. There is mounting evidence that endoplasmic reticulum (ER) stress and activation of the transcription factor, nuclear factor κB (NFκB), are involved in the pathophysiology of obesity, although the majority of studies have focused on the periphery and/or central nervous system (CNS) metabolic homeostasis regions. Recently, we have shown that angiotensin II (Ang-II) induces ER stress and NFκB activation in central cardiovascular control regions of the brain. In line with this, our preliminary data suggests that DIO-induced hypertension is associated with ER stress and NFκB activation in critical CNS neuro-cardioregulatory areas, including the subfornical organ (SFO) and paraventricular nucleus of the hypothalamus (PVN). Using an approach that combines genomic interventions, innovative imaging techniques and integrative cardiovascular physiological analysis in mice, we will test the overall hypothesis that Ang-II-induced-ER stress-mediated activation of NFκB in the SFO-PVN axis mediates increased SNA and hypertension caused by DIO. This includes two Aims during the mentored phase and a third Aim during the independent phase. Specific Aim 1: DIO hypertension is associated with Ang-II type 1a receptor (AT1aR)-mediated activation of NFκB in key CNS cardiovascular nuclei. The mechanisms by which nutritional excess translates into sustained elevations in arterial blood pressure remain unclear. A potential means is by evoking long-term changes in gene expression in CNS cardiovascular neurons through the activation of transcription factors such as NFκB. Interestingly, Ang-II is strongly linked to NFκB activation in animal models of hypertension. Our preliminary in vivo bioluminescence imaging data reveal dynamic activation of NFκB in CNS cardiovascular nuclei during DIO-induced hypertension. Furthermore, our data implicates central Ang-II signaling in DIO hypertension. Building on these findings we propose the following studies: 1.1 Use viral gene transfer, combined with in vivo bioluminescence imaging, to spatiotemporally map and quantify NFκB activation in select CNS nuclei of mice during DIO hypertension. 1.2 Use in vivo bioluminescence imaging and CNS site-selective deletion of AT1aR in AT1aRflox mice to examine the role of AT1aR in DIO-induced NFκB activation in select CNS nuclei. Specific Aim 2: AT1aR-induced ER stress mediates NFκB activation in key CNS cardiovascular nuclei during DIO hypertension. The ER is now recognized as the primary sensor and facilitator of adaptation to cellular stresses. Chronic activation of ER stress pathways leads to long-term changes in cellular function, which contribute to metabolic and cardiovascular diseases. Recent evidence has emerged that certain branches of the ER stress pathways directly intersect with NFκB activation. Our key preliminary data show that DIO hypertension is associated with both ER stress and NFκB activation in the CNS, and that chemical inhibition of ER stress in the brain prevents Ang-II-induced NFκB activation. We propose the following: 2.1 Determine if DIO-induced ER stress in CNS cardiovascular nuclei is mediated via AT1aR using targeted viral delivery of Cre recombinase in AT1ARflox mice. 2.2 Examine if relieving ER stress via targeted viral delivery of the ER chaperone GRP78 in select CNS nuclei prevents NFκB activation during DIO-dependent hypertension. Specific Aim 3: NFκB activation in the SFO-PVN axis is causally linked to the pathogenesis of DIO- induced sympathetic activation and hypertension. The overarching hypothesis of this proposal is that DIO- induced hypertension and sympathetic overactivity are caused by long-term alterations in the function of neuronal synapses and networks, which are ultimately encoded by changes in gene transcription. Our preliminary data highlight Ang-II and ER stress-induced NFκB activation as strong candidates in the signal transduction pathways related to cardiovascular and autonomic function. During the independent phase the PI will test the functional role of NFκB in the SFO-PVN axis in mediating DIO-induced sympathetic overactivity and hypertension. We propose the following: 3.1 Determine if selective inhibition of NFκB activation in select CNS nuclei alleviates DIO-dependent sympathetic activation and hypertension via targeted viral delivery of a dominant-negative inhibitor of NFκB. The findings from these studies will provide insight into the underlying molecular mechanisms driving DIO- induced neurogenic hypertension. Considering the prevalence of obesity and the associated hypertensive state, defining a potential link between Ang-II-induced ER stress and NFκB activation may lead to novel therapeutic targets to treat hypertension in obese conditions. Furthermore, studies such as this have the potential to open new avenues in neuro-cardiovascular research; thus laying the framework for future independent investigations. The innovative research and training environment during the mentored portion of this proposal (Aims 1 and 2) will provide the PI with the necessary support to develop, implement and advance this novel area of research in preparation for the next independent phase (Aim 3).